Longitudinal Quality of Life and What Matters Most to Older Adults with Indolent Non-Hodgkin Lymphoma

Project Summary
Older adults undergoing cancer treatment prioritize quality of life (QOL), which encompasses crucial domains
such as physical functioning, physical health, and social well-being. Advances in therapies have extended
survival for many cancers, transforming some, including various blood cancers, into chronic conditions.
Indolent non-Hodgkin lymphomas (iNHL) are one group of such cancers that exemplify the challenges for
these incurable cancers in which disease control must be balanced with other medical considerations such as
life expectancy, medical comorbidities, frailty, and functional status. Unfortunately, current guidelines for iNHL
lack a focus on QOL, which can leave older patients at risk for over- and under-treatment, leading to excess
worry, distress, and monitoring from their healthcare that may not improve or extend their life.
Our study will describe how older adults with iNHL experience QOL using a large existing lymphoma cohort
study and direct patient narratives. By evaluating their lived experiences and priorities using quantitative survey
data (Aim 1) and qualitative interview data (Aim 2), we will provide a detailed description and examination of
their essential connections and associations. These insights will inform future care interventions for
subsequent research that will help address the needs of older patients with these (and potentially other)
chronic cancers.
This proposal will deploy geriatric and supportive care principles to build foundational knowledge to eventually
improve the holistic management of older adults with iNHL. This proposed project will also serve as a crucial
first step in the principal investigator’s maturation as an aging researcher devoted to caring for older adults with
blood cancers.

Public health relevance
Project Narrative Quality of life is a top priority for older adults undergoing cancer treatment, and it is especially important to study as cancers become chronic conditions in the era of newer therapies. Older adults with indolent non- Hodgkin lymphomas are a model population to understand the lived experiences and priorities of older adults with chronic cancers. This proposal uses rigorous quantitative and qualitative methods to analyze longitudinal quality of life patterns and conduct in-depth interviews about what matters most to older adults with indolent lymphomas with the goal of developing foundational knowledge that will contribute to enhanced patient- centered care models for older adults with chronic blood cancers.